Cell & Molecular Imaging Shared Resource

CELL & MOLECULAR IMAGING SHARED RESOURCE: SUMMARY
The mission of the Cell & Molecular Imaging Shared Resource (CMI) is to provide Hollings Cancer Center
(HCC) members with technologies, expertise, and training for state-of-the-art cell-based imaging and analysis.
Imaging platforms provided include confocal, multiphoton, and super-resolution microscopy of live and fixed
cells and tissues, intravital imaging, automated imaging, and image quantification of histological slides. CMI
houses Zeiss LSM 880 NLO multiphoton/confocal/Airyscan super-resolution, Olympus Fluoview FV1200
intravital multiphoton, Zeiss LSM 510 META confocal, Olympus Fluoview FV 10i LIV live cell confocal, and BD
BioSciences CARV II spinning disk confocal microscopes, and a new Perkin-Elmer Vectra Polaris Automated
Quantitative Pathology Imaging System. Microscopes are equipped with environmental chambers for
temperature and CO2/O2 control to allow high-resolution non-destructive 3D imaging of living cells and
organisms. Applications include: 1) live cell imaging of parameter-sensitive fluorophores to monitor ions,
electrical potentials, radical generation, pyridine nucleotide reduction, membrane permeability, cell viability
(apoptosis and necrosis), fluorescent protein labeling, and other fluorescent reporters; 2) high resolution
imaging of tissue sections for immunocytochemistry and fluorescent protein distribution; 3) fluorescence
resonance energy transfer (FRET) and Duolink to characterize and quantify intermolecular interactions; 4)
intravital microscopy to monitor microcirculation, leukocyte margination, mitochondrial polarization and
permeability, and other factors in living animals; and 5) high throughput, quantitative multiplexed imaging of
conventionally and immunostained specimens. Ancillary equipment includes tissue culture hoods, incubators
and fluorescence and absorbance plate readers for parallel measurements in cultured cells grown on multi-well
plates. Through the Department of Pathology and Laboratory Medicine, CMI also provides consultation,
training, and services in histopathology (frozen and paraffin sections and immunocytochemistry) and
correlative electron microscopy. CMI services include theoretical and hands-on training and assistance to
junior investigators. Imaging workstations running Imaris, ImageJ FIJI, Metamorph, and other software provide
offline image processing and analysis. In the current cycle, CMI supported research in 54 HCC labs leading to
40+ publications by 23 investigators representing all HCC research programs and submission of 50+ grant
proposals, including a P20 Center of Biomedical Research Excellence (COBRE) on “Oxidants, Redox Balance,
and Stress Signaling” (P20 GM103542), plus pending applications for a COBRE in Diseases of the Liver and
Gastrointestinal Tract, and a P30 Digestive Diseases Research Core Center. Under the leadership of John J.
Lemasters, MD, PhD, a national leader in mitochondria and energetics biology, the CMI Shared Resource has
grown to become a superb scientific resource for the visualization and quantification of cellular processes.